ROLE OF ALVEOLAR MACROPHAGE DERIVED FIBROGENIC GF IN CHRONIC LUNG DISEASE

The purpose of this study is to improve our understanding of how and why some premature infants develop chronic lung disease, while others recover from their early lung disease without any further problems.